An R2 non-neuroinvasive herpes simplex virus type 2 vaccine

PROJECT SUMMARY
There is an unmet need for a herpes simplex virus (HSV) vaccine. We propose to
develop a live-attenuated HSV-2 vaccine based on our R2 technology platform. R2
vaccines show unprecedented safety and efficacy in animal models, and offer
antigenicity superior to subunit/mRNA and single-round vaccine designs. R2 vaccines
are also the first live-attenuated alphaherpesvirus vaccines that lack neuroinvasive
potential, and thereby are incapable of establishing life-long infections in the nervous
system. In phase I of this fast-track STTR application, we propose to: (i) produce a HSV-
2 self-excising infectious clone of a low-passage clinical isolate, (ii) use the clone to
produce a HSV-2 R2 recombinant, and (iii) characterize the R2 vaccine in culture side by
side with our existing HSV-1 R2 vaccine candidate. In phase II, the HSV-2 R2 vaccine
will be tested for safety, immunogenicity, and efficacy in mice and guinea pigs. This work
will provide the foundation to advance product development to clinical trials.

Public health relevance
PROJECT NARRATIVE HSV-2 is a sexually-transmitted infectious (STI) agent that is responsible for painful genetical blisters in approximately 15% of the population: 40-80 million people globally are estimated to suffer from recurrent symptomatic genital infections. The virus can be transmitted to neonates during birth where encephalitis can result in long-term neurologic deficits and disseminated infections are life threatening. The goal of these studies is to develop an HSV-2 non-neuroinvasive live-attenuated vaccine based on our established R2 technology. The vaccine will be tested for safety, immunogenicity, and efficacy in preparation for clinical trials.